Deciphering Dentate Gyrus Malfunction in Age-Dependent Hippocampal Hyperactivity: Implications for Psychogenesis

PROJECT SUMMARY
The dentate gyrus (DG), a part of the hippocampus (HPC), plays a pivotal role in encoding and retrieving episodic
memory. A mounting body of research implicates HPC abnormalities, including those in the DG, in the
pathophysiology of psychosis. This includes observed structural and functional changes in the HPC of individuals
suffering from psychosis, such as those diagnosed with schizophrenia (ScZ). Pertinently, studies have identified
decreased neurogenesis and changes in the morphology and functionality of DG granule cells in both animal
models of psychosis and postmortem brain analyses of ScZ patients. ScZ is a complex mental disorder marked
by a mix of symptoms: hallucinations, delusions, disorganized thinking, and impaired social functioning. The
onset of ScZ varies, but there's a known age dependence with symptoms typically appearing from late
adolescence to early adulthood, generally between the late teens and early thirties. Emerging evidence proposes
a potential correlation between age-dependent dysfunction in the dentate gyrus (DG) and psychosis, although
the exact nature of this relationship remains unclear.
In this proposal, our objective is to reverse-translate discoveries from post-mortem human brain analyses. We
specifically target DG excitatory neurons, aiming to modulate them using the chemogenetic technique known as
DREADD (Designer Receptors Exclusively Activated by Designer Drugs) to gradually inhibit DG activity in the
HPC in an age-dependent fashion. Concurrently, we will longitudinally monitor HPC activity using a chronic high-
density in vivo recording strategy. Our hypothesis is that a reduction in DG activity in the HPC will instigate
abnormal hyper-excitable neuronal activity in downstream CA3 / CA1 regions during adolescence, propagating
into the entorhinal cortex (EC), which will subsequently disrupt normal brain activities, including oscillatory
patterns and neuronal spiking activities, post adolescence. Preliminary data show the emergence of large,
spontaneous, irregular hypersynchronous activity in the HPC, which evolves over time and persists into
adulthood in mice. This spontaneous activity is characterized by large transient local-field potential (LFP)
deflections coupled with large population spiking activity that has a temporal structure lasting for 50-100
milliseconds. Notably, these hyper-synchronous events tend to occur during quiet wake or slow-wave sleep
periods, but not during active running states.
Our aim is to consolidate two working hypotheses in this grant period: (i) how gradual suppression of DG triggers
the hyper-synchronous events in HPC; (ii) the how the hyper-synchronous events impact normal sharp-wave
ripples (SWRs) and behavior. We anticipate that our modeling and investigation of the early onset of ScZ,
extrapolated from post-mortem brain analyses of human patients, will illuminate the neurological processes
occurring in the adolescent brain during quiet / sleep periods, and aim to eventually submit a full five-year
research proposal.

Public health relevance
PROJECT NARRATIVE The Dentate Gyrus (DG) in the hippocampus is a crucial subregion for information from nearby cortical regions, and its reduced function in schizophrenia (ScZ) patients is often accompanied by heightened activity in Cornu Ammonis subregions CA3/CA1. Our study aims to replicate this phenomenon in animal models by precisely manipulating DG activity over time. We will then monitor the DG and CA subregions as well as adjacent entorhinal cortex areas using high-density in vivo electrophysiology.